COACH: COmmunities Aligned to reduce Concussion and Head impact exposure in youth football

Project Summary
Football has a high risk of concussion and incidence of subconcussive head impacts which have long-lasting
negative effects on brain health. With roughly 3.5 million athletes participating in youth football each year, there
is a critical need to reduce head impact exposure and concussion risk. Over an entire season, most of an
athlete’s head impact exposure is attributed to practice. Coach-directed activities (e.g., practice drills) influence
the frequency and severity of head impact exposure. Practices are amenable to intervention; however, youth
football leagues are often community-run organizations with limited resources, making implementation and
enforcement of injury prevention strategies a challenge. Thus, engaging community members is essential for
successful development, implementation, and sustenance of interventions. We partnered with a community
stakeholder group to co-design and implement an evidence-based intervention program: COmmunities Aligned
to reduce Concussion and Head impact exposure (COACH). COACH seeks to improve knowledge and skills of
youth football coaches in effective practice planning that incorporates safe drills and to change attitudes and
beliefs toward contact in practice. COACH has been pilot tested in two teams and shown to be acceptable and
feasible. A critical next step of this research is the pragmatic evaluation of the effectiveness of COACH on a
larger scale, while identifying factors that influence implementation. This proposal addresses this critical next
step by determining the capacity of youth football organizations to adopt COACH and by testing COACH’s
effectiveness while monitoring the implementation process. In Aim 1, we will engage youth football organizations
in a mixed methods evaluation of capacity to adopt COACH. Semi-structured focus groups with coaches and
parents, and interviews with organizational leaders from a diverse sample of youth football organizations will be
conducted. We will measure organizational needs, capacity, culture, and readiness to adopt COACH. Data will
be used to inform ways to strategically adapt COACH prior to implementation using a community-engaged
approach. In Aim 2, we will use a stepped-wedge design to test the effectiveness of COACH at reducing head
impact exposure in practices and adverse neurobehavioral health outcomes. Over four years, athletes enrolled
across six organizations will be recruited to participate in parallel biomechanical data collection with an
instrumented mouthguard to evaluate the effectiveness of COACH at reducing head impact exposure. A sub-
sample of athletes will complete pre- and post-season neurobehavioral health and cognitive assessments. Head
impact exposure and changes in neurobehavioral health outcomes will be compared across the control and
intervention teams. In Aim 3, we will evaluate implementation outcomes via on-field video and field notes. We
will also conduct a mixed methods assessment of contextual factors that influence adaptation. Successful
completion of this project will help us achieve our goal of increasing equitable access to a safe and effective
practice environment and change the paradigm of safety for young athletes.
1

Public health relevance
Project Narrative Head impacts in collision sports such as football are a public health concern, as repetitive head impacts, even if a concussion is not suspected, have negative effects on brain health. We have partnered with a community stakeholder group to create a safety program for youth football named “COmmunities Aligned to reduce Concussion and Head impact exposure (COACH)”, which seeks to improve knowledge and skills of youth coaches in effective and safe practice planning and to change attitudes and beliefs to prevent head impacts and promote safety. To continue advancing COACH as an approach to prevent head injuries in youth football, this R01 Research Project Grant will determine the ability of youth football organizations to adopt COACH and test if COACH is effective in reducing head impacts, concussion, and negative effects of brain health while monitoring how the program is implemented.